Molecular Imaging in Cancer Biology Training Program

PROJECT ABSTRACT
The central mission of the T32 “Molecular Imaging in Cancer Biology” program (T32 MICB) will be to develop
novel molecular imaging methods, technologies, and platforms that will accelerate the understanding of human
cancer biology as a basis for designing curative cancer therapeutic regimens as well as cutting-edge
diagnostic, prognostic, and therapeutic tools. This overall goal will be achieved under the auspices of three key
themes: (1) “Imaging Fundamental Biology,” (2) “Imaging New Model Systems,” and (3) “Imaging Technology
Development.” This T32 MICB research portfolio is situated at the intersection of various disciplines—from
basic science including chemistry and physics, structural biology, drug development, cell biology, and
developmental biology to cancer biology, invasion and metastasis, and applied disciplines, including
pharmacology, nanotechnology, radiochemistry, engineering, and medicine. Fundamental knowledge about
the biology of cancer has burgeoned, but the translation of basic science discoveries to clinical advancements
can be slow and inefficient; molecular imaging can significantly accelerate this process and a well-trained
population of basic scientists well-versed in all aspects of molecular imaging is crucial to the success of this
endeavor. The faculty preceptors chosen for this T32 MICB reflect the broad range of expertise and are
leaders in their respective imaging fields. They are well-funded and have independent R01 (cancer-related) or
R01-like research support (e.g., R35 or HHMI). To ensure that the trainees (five post-doctoral slots and one
pre-doctoral slot per year) have a full well-rounded training experience (including resilience and well-being) in
preparation for independent careers, our initial design is based on a three-year training program for
both the postdoctoral fellows and the predoctoral graduate student trainees. Prior to entry into the T32 MICB
program and during the program, the trainees will be informed about the mission of the T32 MICB
program, which is to produce scientists with specialized knowledge in advances in cancer biology
and imaging technology, within a culture of respect and engagement. Furthermore, trainees will be informed
about expected achievements during the program and that their progress will be continuously evaluated and
benchmarked.

Public health relevance
PROJECT NARRATIVE The central mission of the T32 “Molecular Imaging in Cancer Biology” (MICB) program will be to develop novel molecular imaging methods, technologies, and platforms that will accelerate the understanding of human cancer biology as a basis for designing curative cancer therapeutic regimens as well as cutting-edge diagnostic, prognostic, and therapeutic tools. The main objective of this T32 MICB training grant is to produce scientists who are highly trained in the fundamentals of molecular imaging. The proposed program will educate trainees in multiple aspects of molecular imaging and in the need for conversing and collaborating across a wide spectrum of disciplines.